Sensory Mechanisms in Primary Muscle Tension Dysphonia

PROJECT SUMMARY/ABSTRACT
An estimated 2-8 million people in the United States struggle with primary muscle tension dysphonia (pMTD)—
a functional voice disorder that adversely impacts daily living, occupational productivity, and quality of life and
results in $2 billion in lost annual productivity costs due to absenteeism. Although pMTD leads to the same
emotional, social, financial, and occupational hardships as organic, structural, and neurological voice disorders,
its pathophysiology is poorly understood. These gaps make it difficult to understand what causes symptom com-
plaints of vocal fatigue, vocal tract discomfort, odynophonia, and difficulties projecting or speaking for prolonged
periods in patients pMTD—especially in the context of a lack of overt structural or neurological laryngeal abnor-
malities. Although muscle tension and hyperfunction in the laryngeal system is the most proposed mechanism
underlying symptoms, it is largely theoretical and based on anecdotal observations.
Recent studies from the PI’s lab using well-vetted and validated physiological metrics to quantify tension and
hyperfunction in the (para)laryngeal muscles found no group differences between patients with pMTD and
healthy controls. However, patients with pMTD consistently reported significantly higher vocal effort, vocal fa-
tigue, and vocal tract discomfort with voice use across these studies and self-reported significantly different
sensory experiences on measures of interoceptive awareness. These findings suggest altered sensations with
voice use in patients with pMTD may be an alternative mechanism underlying symptomology to simply muscle
tension or hyperfunctional motor output.
We test the central hypothesis that the somatosensory system plays a role in pMTD signs and symptoms across
two aims. In Aim 1, we compare laryngeal sensation to pMTD symptom severity in patients with pMTD and
controls using laryngeal aesthesiometer sensory testing. In Aim 2, we compare paralaryngeal and widespread
musculoskeletal sensation to pMTD symptom severity in patients with pMTD and controls using mechanical
pressure and dynamic temporal summation quantitative sensory testing (QST) assays.
Outcomes of this proposal will elucidate the role of localized and central sensory mechanisms in pMTD and will
lead to improved diagnostics and management for this debilitating voice disorder.

Public health relevance
PROJECT NARRATIVE Primary muscle tension dysphonia (pMTD) is a functional voice disorder that impacts communication, occupation, and quality of life. Although muscle tension and hyperfunction in the laryngeal system is the prevalent theory underlying patient symptoms of vocal effort, fatigue, and discomfort, previous studies comparing well-vetted physiological laryngeal muscle metrics and self-reported symptoms from our lab suggests pMTD may have more to do with an altered sensory system than aberrant motor patterns. The goal of this proposal is to elucidate the role of sensory mechanisms in pMTD and their relationship to pMTD symptomology.